Data Science Core

CORE 4 PROJECT SUMMARY
DATA SCIENCE CORE
The mission of the Data Science Core (Core #4) is to serve as the focal point from which Program Project
investigators can draw statistical, bioinformatic, and informatics expertise for the completion of their lung
research projects. Core #4 members have extensive experience in applied cancer biostatistics and
bioinformatics and will be involved in all projects to help investigators with the data science needs of their
projects. As studies proceed, Core #4 members will contribute to the refinement of standard operating
procedures in response to realities of fieldwork, integrate data, conduct data quality-control studies, and produce
necessary reports. As projects yield results, the Core #4 will conduct analyses and assist investigators with the
preparation of presentations and manuscripts. To achieve the overarching goal to develop a comprehensive
research program focused on the translation of new treatments for lung cancer the Core #4 has the following
specific aims. Aim 1: To provide statistical expertise from project initiation through completion. The Core #4 will
support all statistical analyses required for the completion of the projects, including but not limited to:
experimental design (randomization); power calculation; statistical association analysis of molecular data
(metabolomics, transcriptomic); and analysis of data from in vitro and in vivo models. Aim 2: To provide
bioinformatics analysis and support for the research projects. Using state of the art bioinformatics tools the Core
#4 will analyze various types of high-dimensional, molecular data, such as data generated via sequencing or
mass spectrometry resulting from the various projects. Aim 3: To provide database and data integration services
for projects and cores. As part of Aim 3, the Core #4 will develop the Lung Cancer Data Repository (LCDR) to
storage all data and metadata related to the experiments into a single virtual location for cross-project integration.
In summary, the Core #4 will provide value and scientific impact to the proposed projects through quantitative
expertise aligned with the goal of determining metabolic vulnerabilities in lung cancer that would lead to new
treatment strategies for lung cancer patients.

Public health relevance
CORE 4 PROJECT NARRATIVE DATA SCIENCE CORE The Data Science Core (Core #4) is an integral part of the research mission of this P01 to identify metabolic vulnerabilities in lung cancer. The goal of the Core #4 is to provide comprehensive, multidisciplinary expertise to support the data science needs of program investigators, with a focus on reproducible research. The Core #4 consists of faculty and staff with a diverse skill set and expertise in providing data science support in the areas of biostatistics, statistical genomics, bioinformatics, and informatics.